Administrative Core

PROJECT SUMMARY - Administrative Core
The Translational Global Infectious Disease Research (TGIR) Center of Biomedical Research Excellence
(COBRE) is dedicated to the development of junior faculty research careers and the growth of institutional
strength in this theme. The Administrative Core of the TIGR COBRE serves as the central administrative,
fiscal, and scientific/educational hub for the overall program. The broad tasks of the Administrative Core
include the selection, support, and mentoring of Research Project Leaders (RPLs); recruitment of new faculty;
oversight of two research core facilities (Human and Population Research, and Mathematical and
Computational Predictive Modeling); all academic and career development programs; and ongoing
assessment and innovative strategic planning for continued growth and sustainability. Three additional
programs are run by the Administrative Core: Mentoring, Visiting Scholars, and Pilot Project awards. The
Administrative Core coordinates interactions with the advisory committee, the University, and the local and
regional IDeA state partners, and assures proper regulatory and fiscal management. Director and Co-Director
Beth Kirkpatrick, MD and Christopher Huston, MD lead the Core and its decision-making ”leadership team”
which also includes the research core directors. In Phase 2, the Administrative Core will support four initial
RPLs, recruit three new external faculty, and continually improve the mentoring, pilot award program, and RPL
pipeline programs. Two graduated project directors have become Co-Investigators and will lead new mentoring
and grant-writing initiatives to expand opportunities for junior faculty and the growing institution-wide team. The
Core will also support a modified Advisory Committee and new initiatives for expanding networking and
research collaborations for junior faculty, including UVM-led scientific research conferences, a visiting scholar
program, and an infrastructure to support multi-disciplinary grant submissions.